Exploring the dynamic tumor-immune ecosystem of breast cancer in heterogeneous tumor microenvironments

ABSTRACT / PROJECT SUMMARY
In breast cancer, interactions between suppressive components of the immune system contribute to the lack of
efficacy of immunotherapies. This project will use mechanistic computational modeling to understand the
tumor-immune ecosystem of breast tumors and guide strategies to improve immunotherapy.
The main objective of this proposal is to quantitatively study and model the tumor-immune microenvironment
in breast cancer. We will use an integrated approach combining computational modeling of the spatiotemporal
organization of the breast tumors with quantitative experiments. The overarching hypothesis is that
constructing a computational model whose long-term states match tumor characteristics identified in vivo can
successfully predict the spatiotemporal behaviors and effects of immunotherapies for breast tumors. The
outcomes of this project are a validated computational model of the tumor-immune ecosystem and new
quantitative insights into how immunotherapies can be more strategically employed in breast cancer. This work
builds on the PIs’ extensive experience in modeling and analysis of cancer cell behavior and tumor growth
(Finley) and clinical oncology and immunotherapy (Roussos Torres).
To establish a predictive framework of the breast tumor microenvironment (TME), we will construct an agent-
based computational model that captures the tumor-immune ecosystem and cell-cell interactions (AIM 1). In
parallel with development of the computational model, we will quantify MDSC immunosuppressive function,
measure tumor growth dynamics, and profile the composition and spatial organization of advanced breast
tumors using an established in vivo mouse model of breast-to-lung metastasis (AIM 2). These data will be
used to calibrate the computational model using a novel approach to leverage tumor imaging data. We will
apply the calibrated model to determine how individual cell-cell interactions and cellular properties affect tumor
composition, spatial organization, and response to immunotherapies (AIM 3). We will investigate how cell-cell
interactions affect tumor growth and simulate a range of immunotherapies to determine the cell properties and
interactions that influence response. The effective immunotherapeutic strategies will be tested in vivo and
validated using human tumor samples.
This project leverages a physical sciences perspective to drive cancer research, leveraging experiment-based
mechanistic modeling of the tumor-immune ecosystem. Upon completion of this project, we will: (1)
quantitatively illuminate the impact of cell-cell interactions on metastatic breast tumor growth, (2) predict the
effects of immunotherapy strategies for metastatic breast tumors, and (3) test the predicted strategies in vivo.
We will pursue in silico, in vivo, and ex vivo studies, ultimately paving the way for clinical translation. Our work
will provide quantitative understanding of the tumor-immune ecosystem in breast tumors and aid in the
development of effective immunotherapy for this devastating form of cancer.

Public health relevance
PROJECT NARRATIVE The presence of multiple tumor cell subpopulations, immune cells, and stromal cells in the tumor microenvironment (TME) can give rise to complex interactions that: promote tumor progression, influence the responses to treatment, and contribute to therapeutic resistance. In advanced breast tumors, these interactions particularly contribute to the lack of efficacy of immunotherapies. This project will use multi-scale computational modeling of the tumor-immune ecosystem to understand the TME of advanced breast tumors and guide the development of strategies to improve immunotherapy.